Investigating The Role of Hippo Signaling in Sinoatrial Node Development

Project Summary/Abstract
Cardiac arrhythmias are one of the leading causes of cardiac-related mortalities worldwide and can arise from
sinoatrial node dysfunction (SND). The sinoatrial node (SAN) is the heart's natural pacemaker and contains
specialized cardiomyocytes (CMs) called pacemaker cells (PCs) that generate spontaneous action potentials to
contract the cardiac chambers. Although the SAN is essential for maintaining rhythmic heartbeats, it is the least
understood cardiac entity. Recent efforts in SAN research have focused on engineering a biological pacemaker
to replace dysfunctional SANs. However, this requires a deep understanding of the mechanisms regulating SAN
development, which is currently limited. Given the technical challenges, only a few transcription factors (TFs),
such as Tbx3, Isl1, and Shox2, have been identified to regulate the SAN gene program. The fundamental Hippo
signaling pathway plays critical roles in cardiac development and regeneration. Our lab recently discovered
Hippo signaling as a critical regulator of adult SAN homeostasis. We effectively inhibited Hippo activity in mice
by knocking out Hippo's core kinases Lats1/2 exclusively in PCs, which resulted in dysregulated calcium
handling and fibrosis. Hippo signaling is also known to govern heart size by regulating CM cell state during
development. Despite Hippo's critical roles in multiple cardiac contexts, its function in embryonic SAN
development remains unknown. My preliminary data suggests that Hippo signaling regulates PC proliferation
partially through the activation of IGF signaling, a known cardiac pro-growth signaling pathway. Additionally, my
preliminary data suggests that Hippo signaling regulates SAN TF Tbx3 and calcium ion channels to influence
PC function. Given my strong preliminary data, I hypothesize that Hippo signaling regulates SAN morphogenesis
and function during embryonic development. To test my hypothesis, I have obtained a novel mouse model where
Cre recombinase is more specific to the embryonic SAN region compared to existing Cre drivers. Using this
mouse model, I will conditionally knock out Lats1/2 in the embryonic SAN. In Aim 1, I will elucidate the role of
Hippo signaling in SAN morphogenesis by analyzing signaling activity, proliferation, and IGF signaling
components upon Hippo inhibition. In Aim 2, I will investigate Hippo's role in regulating the SAN gene program
and PC function. This project aims to elucidate how Hippo signaling regulates SAN development. The findings
from this proposed study will shed light on the molecular mechanisms regulating SAN development and will
discover novel insights for advancing the field in the generation of a biological pacemaker.

Public health relevance
Project Narrative The sinoatrial node is the heart's primary pacemaker, and its dysfunction can lead to cardiac arrhythmias, which is a leading cause of cardiac-related mortalities. Despite the sinoatrial node's critical function, it is the least understood cardiac entity and the molecular regulation underlying its development is largely unknown. This project aims to explore how Hippo signaling, a fundamental pathway for proper organ development, regulates sinoatrial node morphogenesis and function during embryonic development; thereby advancing our understanding of the genetic mechanisms, contributing to future medical advancements for treating cardiac arrhythmias.